Alzheimer Pathology and Neurovascular Dysfunction

Alzheimer’s disease and related dementias (AD/ADRD) are leading causes of age-related
cognitive impairment, currently untreatable. Increasing evidence indicates that functional
alterations of the cerebral microcirculation may play a role in the pathogenesis of AD/ADRD by
reducing the cerebral blood supply. The health of the brain requires a continuous supply of O2
and nutrients through blood flow, tightly matched to its dynamic and regionally diverse energy
needs. Accordingly, neural activity increases blood flow in active brain regions (functional
hyperemia). Functional hyperemia depends in large part on the link between NMDA receptor
activity and neuronal production of the potent vasodilator nitric oxide (NO), and requires tissue
plasminogen activator (tPA) for its full expression. The microtubule associated protein tau is a key
pathogenic factor in AD and other ADRD caused by tau mutations (tauopathies), but little is known
about its role in the neurovascular dysfunction associated in with AD/ADRD. Studies during the
previous funding period have discovered that tau disrupts the link between NMDA receptor activity
and NO production and suppresses functional hyperemia. Since, in tauopathies, including AD,
neocortical neural networks are hyperactive, the failure of functional hyperemia could be
particularly damaging by reducing the brain’s O2 supply in the face of the increased energy
demands caused by aberrant network activity. In this renewal application we seek to address this
critical issue by elucidating the neural and microvascular bases of the effects of p-tau on
neurovascular coupling and on neural network activity, and their impact on brain O2 delivery. To
this end, we will test the hypothesis that the neuronal NO deficit induced by p-tau disrupts the
microvascular bases of functional hyperemia and leads to neural network hyperactivity, which, in
turn, results in a potentially harmful reduction in brain O2. To this end, we will use advanced
imaging approaches in awake PS19 mice, a tauopathy model, to test the following hypotheses:
(a) The NO deficit induced by p-tau leads to aberrant neural network activity and disrupts the
orderly microvascular events underlying functional hyperemia; (b) The combination of aberrant
neural network activity and impaired functional hyperemia leads to reduced brain O2 availability,
rescuable by O2 supplementation; (c) Restoring neuronal NO production with tPA counteracts
neurovascular dysfunction, network hyperactivity, and reduced brain O2, and ameliorates tau
pathology and cognitive dysfunction. These studies will unveil a new aspect of p-tau pathobiology
related to a deleterious mismatch between O2 supply and demands, and may provide the
mechanistic bases for new therapies for AD and other tauopathies.

Public health relevance
Alzheimer’s disease and related dementias are leading causes of cognitive disability in the elderly that have a devastating impact on millions of lives in the US, while imposing a major burden on caregivers and on the economy of the whole health care system. The present application seeks to explore the novel hypothesis that tau, a major cause of damage in these diseases, exerts its deleterious effects on cognitive function by limiting the cerebral blood supply and starving the brain of oxygen. The findings deriving from the proposed studies will advance our knowledge of the vascular contributions to Alzheimer’s disease and related dementias and may suggest new therapies for these highly prevalent yet untreatable conditions.